Genetics of Functional Interactions in Yeast

DESCRIPTION (provided by applicant): The long-term goal of this grant is to exploit budding yeast, Saccharomyces cerevisiae, as a model system for studying eukaryotic biology and its evolution at the system level. One of our specific aims is to deploy methods we have developed that make it possible to perturb steady- state growth in chemostats by inducing exactly one gene or degrading exactly one protein. By following changes in gene expression thereafter, we can observe the direct and indirect consequences of the perturbation genome-wide. The dynamic resolution we can achieve makes it possible to infer causation from temporal order, where previously only correlation was possible. We plan (i) a genome-scale survey (already begun) of the consequences of induction of the known transcription factors in yeast, (ii) the development of synthetic transcription factor based on zinc-finger proteins, (iii) the adaptation of nuclear hormone receptors (in addition to the estrogen receptor), all of which will allow (iv) more sophisticated perturbations, including especially pulses of induction followed by degradation. We will explore the possibility that these methods will produce useful information about regulators other than transcription factors, such as protein kinases, protein phosphatases, acetylating and de-acetylating enzymes, etc. All of these data will be used to construct quantitative models of regulation, as we recently did for the regulation of the combinatorially controlled sulfur assimilation pathway. A second aim is to survey the genes in which mutations contribute to fitness in evolving populations of yeast, exploiting our recent study of the dynamic trajectories of beneficial sterile mutations in 600 cultures grown for 1,000 generations. By deep sequencing of the populations over time we will find and follow the diverse mutations in the standing variation that allow subsequent sterile mutations to sweep. In this way we can test further the hypothesis that the constraints of the cellular system biology impose limitations on the number ways increased fitness can be achieved. We will develop fast methods to distinguish causal mutations from the passenger mutations, and reconstruct fitter variants de novo as a test of our inferences. We will study (i) the dynamics of passenger versus causal mutations in populations where the sterile mutation failed to sweep; (ii) comparisons of relative fitness of diverse combinations of beneficial mutations from independent cultures; (iii) characterization of the genome wide expression phenotypes of fitter variants. We hope these methods will shed light on the development of human tumors which, like the yeast in a chemostat, evolve ever-more-fit variants that grow faster in an essentially constant environment.

Public health relevance
PUBLIC HEALTH RELEVANCE: We study growth of yeast because much of what we find in yeast applies to humans, both at the level of individual proteins, and at the level of cellular system integration. This gives us reason to believe that our results will shed light on the development of human tumors which, like the yeast, constantly evolve ever-more-fit variants that grow faster in an essentially constant environment. __SpecificAimsTextDelimiter__ SPECIFIC AIMS For more than two decades, the long-term goal of this grant has remained "to exploit budding yeast, Saccharomyces cerevisiae, as a model system for studying eukaryotic biology". It became clear to me very early in my career that the most basic processes of eukaryotic biology are likely to be the most conserved; we exploited this idea to study the actin and tubulin cytoskeletons. It always made sense to me to focus on the most fundamental (and often most difficult) issues, thereby hoping to take maximum advantage of the experimental advantages of yeast (cf. Botstein and Fink, 1988). The advent of the genomic sequences and the technologies of functional genomics (particularly well-developed and powerful for yeast) made it possible, for the first time, to study basic eukaryotic biology at the "system level" (cf. Hartwell et al. 1999). Previously one was limited to studying individual processes, using genetic and biochemical techniques to identify genes and proteins that participate one by one. New genome-scale yeast technologies, some of which my group helped to develop, put yeast, once again, into a leading position as an experimentally tractable model for studying system-level biology (cf. Botstein and Fink, 2011). At the cellular system level, we have every expectation that much of what we find in yeast may apply other eukaryotes, just as was the case for the functions of individual cytoskeletal genes and proteins. The Progress Report (below) briefly summarizes what we have accomplished in our studies of growth rate control and homeostasis, regulatory network biology, and experimental evolution. Going forward we will emphasize the latter two areas, as we have obtained independent funding from DARPA for our growth rate control and metabolic cycling studies. Our specific aims are: Specific Aim 1: To exploit, and to develop further, methods for truly gratuitous induction (or degradation) of single proteins which we can use to perturb, very specifically, steady-state growth in yeast. We recently achieved a proof-of-principle that these methods allow us to follow dynamically, by genome-wide gene expression, the direct and indirect consequences of induction or degradation of each of five interacting regulatory proteins that combinatorially control the sulfur assimilation pathway. This aim includes (i) an ongoing genome-scale survey of the consequences of induction of the known transcription factors in yeast, (ii) the development of synthetic transcription factors based on zinc-finger proteins, (iii) the adaptation of nuclear hormone receptors (in addition to the estrogen receptor), all of which will allow (iv) more sophisticated perturbations, including especially pulses of induction followed by degradation. We will explore the possibility that these methods will produce useful information about regulators other than transcription factors, such as protein kinases, protein phosphatases, acetylating and de-acetylating enzymes, etc. This aim also includes the derivation and testing of quantitative and predictive models of complex regulation. Specific Aim 2: To survey the genes in which mutations contribute to fitness in evolving populations of yeast, exploiting our recent study of the dynamic trajectories of beneficial sterile mutations in 600 cultures grown for 1,000 generations. By deep sequencing of the populations over time we will find and follow the diverse mutations in the standing variation that allow subsequent sterile mutations to sweep. We hope to test further the hypothesis that the constraints of the cellular system biology impose limitations on the number ways increased fitness can be achieved. We will develop fast methods to distinguish causal mutations from the passenger mutations, and reconstruct fitter variants de novo as a test of our inferences. This aim includes studies of (i) the dynamics of passenger versus causal mutations in populations where the sterile mutation failed to sweep (ii) comparisons of relative fitness of diverse combinations of beneficial mutations from independent cultures; (iii) characterization of the genome wide expression phenotypes of fitter variants.